NRSA Training Core

The overarching goal of the UCSF Clinical and Translational Science Institute (CTSI) NRSA Training Program
(TL1) is to train succeeding generations of diverse junior investigators in the use of cutting-edge methodologies,
sophisticated analytic techniques, and effective leadership practices to expand scientific knowledge and improve
health. With these foundational skills, TL1 trainees will be positioned to conduct transformative clinical and
translational research with real-world impact. The proposed TL1 training core is composed of two separate
programs: the established and highly successful predoctoral Yearlong Inquiry Program (YIP) for health
professional students and a newly focused Clinical Research Informatics Postdoctoral (CRISP) program for
clinical fellows. The primary goals of the YIP are to train and inspire exceptional and diverse young investigators
to embark on a life-long journey conducting a broad range of transformative clinical and translational research
while enrolled in UCSF's health professional schools. The primary goal of the CRISP program will be to address
the urgent demand for in-depth training in clinical research informatics required to build a robust workforce with
the necessary expertise to tackle health system challenges and become future leaders in this area. These two
programs will introduce predoctoral (YIP) students and postdoctoral (CRISP) fellows to state-of-the-art clinical
research methods in epidemiology, biostatistical analysis, clinical informatics, data science, and responsible
conduct of research. In partnership with other CTSI programs, the NRSA training core will achieve the following
Specific Aims: Aim J1. Expand and enhance the 1-year predoctoral Yearlong Inquiry Program, enrolling
and training up to 11 students per year. J1.1. Mentor and support a diverse group of health professional
students to complete a Masters' degree in clinical research and a research project, while acquiring life-long
research career development skills; J1.2. Provide YIP students with exposure to clinical research informatics
and data science, as well as academic career development and leadership. Aim J2. Establish a Clinical
Research Informatics Postdoctoral program to train clinical fellows in state-of-the-art clinical research
informatics methods and provide mentorship in the design and completion of clinical research
informatics projects. J2.1. Empower a diverse group of clinical postdoctoral fellows to complete coursework in
clinical research and a mentored clinical research informatics project; J2.2. Provide CRISP fellows with training
in clinical research informatics and data science, and academic career development and leadership. Both YIP
students and CRISP fellows will conduct mentored research projects that impact clinical practice, positioning
them to successfully compete for future NIH fellowship or research career development grants, and building the
expertise and enthusiasm to pursue and sustain academic careers as independent investigators.